How do Lay Health Navigators Impact Breast Cancer Screening? (MICEO Supplement);

Breast cancer mortality is greatly reduced when women have mammograms every two years. Increased
mortality is seen if this does not happen. Among African American and Black women, the mortality has been
reported as 40% higher than non-Hispanic Whites. In New York City, our screening rates are lower than the
Health People 2030 goal of 80.5%. We find that African American women in communities with high
proportions for African Americans, have screening rates below this target goal. This project will examine the
potential of recruiting Lay Health Navigator (LHN) college students from underserved communities to navigate
African American and Black women attending our culturally targeted evidence-based education programs to
sites for a mammogram, as needed. We will examine factors related to the recruitment of LHN, including:
recruitment and retention of the LHNs, the fidelity of their work and the cost effectiveness of utilizing navigators
in this way. Our approach to recruitment of LHNs specific to this project is based on the sustainability of the
evidence-based culturally and linguistically targeted health education program, the Witness Project of Harlem,
and the development of our current LHN program for increasing adherence to lung cancer screening. The
Witness Project of Harlem has been developed to target the beliefs and myths identified as facilitators and
barriers to cancer screening for Black and African Americans women. Our outreach initiatives target
organizations in neighborhoods NYC with the highest age-adjusted breast cancer mortality rates per 100,000
residents. Using the navigation assessment tool developed to assess all components of navigation, we will
examine the work of our LHNs including their sustainability and fidelity, our success rate of mammography
increased adherence and the cost effectiveness of a lay health navigation program.
.

Public health relevance
TISCH CANCER INSTITUTE AT THE ICAHN SCHOOL OF MEDICINE AT MOUNT SINAI Principal Investigator/Director: Ramon Parsons, MD, PhD Public Health Relevance Statement: The Tisch Cancer Institute provides an infrastructure to advance basic, clinical and population health cancer research, so as to prevent cancer in healthy individuals and improve the lives of cancer patients and their families in our diverse communities. To accomplish this mission, the TCI has developed collaborative research programs that strive to translate discoveries to new therapies and to develop new prevention and delivery strategies with priority given to cancers affecting our catchment area. The Cancer Clinical Trials Office with its newly established Early Phase Trials Unit provides the infrastructure to conduct novel, investigator initiated protocols developed by TCI investigators.